Investigating a role for eNAMPT-containing extracellular vesicles in mitigating age- and Alzheimer Disease-related cognitive decline

PROJECT SUMMARY/ABSTRACT
The steady erosion of cognitive function is a hallmark of aging and markedly exacerbated in Alzheimer Disease
(AD). These deficits have no effective treatments. Depletion of nicotinamide adenine dinucleotide (NAD+) and
reduction of NAD+-dependent sirtuin activity in aging and AD have been well documented. Restoring NAD+ or
activating the sirtuin SIRT1 has induced abatement of aging symptoms including cognitive decline. However,
current NAD+ replenishment strategies are non-specific and the success of SIRT1 activation as an anti-aging
therapeutic may require tissue-specific activation and the concomitant restoration of NAD+. We have shown
previously that nicotinamide phosphoribosyltransferase (NAMPT), the rate-limiting enzyme in the major
mammalian NAD+ biosynthesis pathway, is contained in extracellular vesicles (EVs) and secreted to plasma.
Treatment of aged mice with plasma-derived EVs containing extracellular NAMPT (eNAMPT) extends mouse
lifespan and healthspan. Our preliminary data suggest that EV treatment can ameliorate cognitive dysfunction
and rescue age-related decreases in hippocampal CA1 synapse counts in 24-month-old mice. EVs are also
targeted to the brain and can increase NAD+ in cultured neurons. However, the tissue-specific EV targeting
mechanism as well as the implications for EV treatment in the context of AD-related cognitive decline remain
unknown. This study will test the hypothesis that EV-contained eNAMPT rescues age-related cognitive
dysfunction via activating SIRT1 in key neuronal populations and that leveraging this pathway can lessen AD-
associated cognitive decline. In Aim 1, cell culture-derived EVs will be utilized to test the necessity of eNAMPT
in the targeting and uptake of EVs both in vitro and in vivo. In Aim 2, the possibility that the cognitive benefits of
EV treatment occur through eNAMPT-mediated activation of SIRT1 will be evaluated. This determination will
be accomplished via EV treatment with and without EV-contained eNAMPT and with and without hippocampal
knockdown of Sirt1 by viral delivery of shRNA. Aim 3 will test the effectiveness of EVs in treating cognitive
deficits and pathological progression in a mouse model of AD. Therefore, this study has the potential to
elucidate a novel role for eNAMPT in facilitating both the cellular targeting of EVs and the efficacy of EVs in
rescuing age- and AD-related cognitive dysfunction. This project may also establish eNAMPT-containing EVs
as a viable biologic to treat cognitive deterioration in aging and AD. This fellowship proposal integrates the
NAD+ biology and aging expertise of sponsor Dr. Shin Imai with comprehensive training in behavioral
neuroscience, AD models, advanced synaptic analysis, EV engineering, and laboratory mentorship and
leadership. This training will be further empowered by the intellectually stimulating and highly collaborative
environment of Washington University in St. Louis. Thus, this fellowship will constitute ideal preparation for the
applicant’s career as the future leader of an academic laboratory.

Public health relevance
PROJECT NARRATIVE There is currently no effective treatment for the cognitive dysfunction characteristic of aging and exacerbated in Alzheimer Disease (AD). Administration of extracellular vesicles (EVs) containing NAMPT, an enzyme critical to cellular NAD+ production, can extend lifespan and ameliorate age-related deficits such as activity levels in mice. This study will evaluate a role for NAMPT in mediating the ability of EVs to target the brain and rescue age- and AD-related cognitive decline, potentially establishing the use of EVs as a viable therapeutic strategy to treat these conditions.